A new deep learning approach to probe the molecular basis of inhalation allergens

ABSTRACT
Inhalation allergy is a major health problem worldwide and is most caused by allergies to grasses, dust mites,
and ragweed. About 45% of the US population is sensitized to one or more allergens from these sources, with
30% of the US population sensitized to ragweed pollen. More than 90% of reactive serum IgE in ragweed-
sensitized patients is against the group 1 allergen, Amb a 1, a non-glycosylated 38-kDa protein that belongs to
the pectate lyase (PL) family. Patients sensitized to ragweed pollen also cross-react to other PL allergens, such
as the mugwort and sunflower allergens, Art v 6 and Hel a 6, respectively. However, it is not known if there are
other PL proteins that could be cross-reacting with these allergens. We hypothesize that artificial intelligence (AI)
technologies that made dramatic improvements in recent years, can clarify this problem. We will use these
innovative technologies to find characteristic sequence and structural features of allergenic PL proteins and
identify new potential PL allergens. As preliminary data, we developed a new convolutional neural network (CNN)
approach, SDAP_AI, which is trained on allergen sequences from our updated Structural Database of Allergenic
Proteins, SDAP 2.0. Our preliminary model achieved a 93.4% accuracy in the test dataset of ten-fold cross-
validation with an 80%/20% partition of training and test data. We also showed a favorable performance of our
CNN model compared to other ML algorithms, such as AllergenFP and Algpred 2. In addition, our SDAP_AI
approach has the potential to clarify what makes a protein allergenic. In the proposed project, we will further
optimize SDAP_AI, assess its robustness by testing the predictions in other independent data sets, and apply
our CNN model to characterize protein allergenicity. We will pursue two aims: 1) optimize a deep learning model,
SDAP_AI, for allergenic proteins using sequence information of allergens in SDAP 2.0 and assess its prediction
quality; and 2) apply SDAP_AI to identify and experimentally validate new potential allergens and IgE epitope
peptides of PL allergens. Potential allergens will be experimentally validated by a peptide microarray assay with
sera from patients sensitized to ragweed pollen. In addition, we also will apply SDAP_AI to reevaluate previously
identified IgE epitopes on PL allergens (e.g., Amb a 1, Jun a 1, Hel a 6) to determine the accuracy of those
epitopes and again validate results by microarray analysis with human sera. We will map linear IgE epitopes on
the surface of PL allergens to define conformational epitopes. This information will help identify common features
that make a protein an allergen and can aid future efforts to predict protein allergenicity. The application of AI
technology to allergen research is novel and our combined experimental and computational approach will yield
a powerful new computational paradigm to identify potential allergenicity of new proteins and help design new
immunotherapies to reduce the burden of inhalation allergies. Source code, documentation for use and example
input files will be available from our SDAP 2.0 website.

Public health relevance
NARRATIVE Inhalation of pollen from trees and grasses causes seasonal allergic diseases, which are responsible for significant clinical burden and societal costs. However, the molecular and structural features of these allergens are poorly characterized, limiting our ability to design more effective immunotherapies to reduce the incidence and impact of allergic diseases. We will leverage powerful artificial intelligence strategies to comprehensively characterize the features of common allergens and to identify new potential allergens against inhalation allergies.